Translational Research Training in Cancer Prevention and Control

Given the severe shortfall of research scientists who are capable of conducting comprehensive studies
that can translate fundamental knowledge from the bench to the clinical and the community settings for the
improvement of cancer prevention and control, the purpose of this research training program is to provide
integrated training in an inter-disciplinary research and teaching setting at the University of Pittsburgh Medical
Center (UPMC) Hillman Cancer Center. Trainees will be trained in understanding the role of environmental
exposures, behaviors and lifestyle factors, genetic and other physiological factors in the development and
progression of cancer in humans. The training program involves cross-disciplinary training courses in different
tracks in the Clinical Trial Research, the Translational Research, and the Population-Based Observational and
Interventional Research on cancer. Trainees will work with experienced mentors in a multiple disciplinary team
conducting research from mechanistic experiments and observational studies in populations to randomized
intervention studies to test the efficacy of cancer-preventive means and strategies in humans. The mentored
research will provide direct research experience to trainees in study design, methodological development,
implementation of research protocol, data collection, analysis and interpretation, and manuscript preparation
and publication. Trainees also will learn how to translate discoveries from pre-clinical experimental and/or
observational studies into randomized interventional studies for cancer prevention and control. The unique
training of this program will train next generation of scientists who can lead the cutting-edge translational
research on cancer etiology, prevention and control.
This training program is a joint effort of 26 preceptors who are conducting active research projects all
with independent research funding in University of Pittsburgh. These faculties are from the following research
programs: the Biobehavioral Cancer Control Program (BCCP), the Cancer Biology Program (CBP), the Cancer
Epidemiology and Prevention Program (CEPP), the Cancer Immunology and Immunotherapy Program (CIIP),
and Cancer Virology Program (CVP) at the UPMC Hillman Cancer, a top-ranked Comprehensive Cancer
Center with $104 million in peer-reviewed direct cost funding in 2023. Trainees will receive cutting-edge
translational research training and experience.
We request continuing funding to support 3 postdoctorates and 1 predoctorate per year for 5 years. Our
recent data on applicant recruitment, retention and training experience demonstrate a relatively large pool of
candidates with high academic performance. In addition, we successfully enrolled more than one-third trainees
from the underrepresented racial and ethnical groups. The progress and success of the training program will
continue to track the career development and research activities of past trainees in the 10 years post-training.

Public health relevance
This training program will create a new generation of researchers superbly trained in multidisciplinary settings with a broad perspective and knowledge concerning basic, epidemiologic and clinical sciences. This new generation of scientists will be competent to undertake multidisciplinary cancer prevention and control research that translates the discoveries in pre-clinical experimental and observational studies into randomized interventional studies for Eliminating the Suffering and Death due to Cancer, the ultimate goal set forth by NCI.